FACULTY RECRUITMENT & DEVELOPMENT CORE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The RCMI faculty recruitment program shall focus on the following research areas for development during this cycle: 1)Research: Immunologist, Molecular Virologist;2)Human genetics: Molecular Geneticist;and 3)Epidemiology: Social Behavior Epidemiologist. Additionally, PSM shall reinforce research faculty in diabetes, cancer, neuroscience, and environmental toxicology areas.